Determining the Role of Bacterial Products on Neuronal Localization and Function in a Symbiotic Organ

PROJECT SUMMARY
Bacteria, such as those found in the vertebrate gut microbiome, have been shown to have widespread
effects on both the enteric (ENS) and central nervous systems (CNS) in numerous animals. Reciprocally, the
ENS has been shown to have an impact on the progression of microbiome establishment in the gut. However,
despite the profound influence of bacteria on neuronal development and physiology, the diversity of the
vertebrate gut microbiome and the complexity of the ENS make the mechanisms underlying these phenomena
difficult to study. Despite the importance of the topic and vertebrate models, these systems involve
microbiomes that are both spatially and compositionally complex, often with thousands of bacterial species that
can very between individual hosts. Therefore there is a role for simple, exquisitely manipulable model systems
in which to study the effects of bacterial symbionts on neuronal development and function. To address the
dearth of such models for the mechanisms by which bacteria influence host neurobiology, we propose to use
the symbiosis between the Hawaiian bobtail squid (Euprymna scolopes) and its luminescent bacterial symbiont
Vibrio fischeri as a tractable system in which to study how bacteria drive host neuronal development. The
squid-vibrio system is a well-established model for the effects of bacterial products on host physiology and
development, with outcomes that are often generalizable to other animal systems. This proposal aims to
develop the squid-vibrio system into a new model for the study of the effects of microbes on host neurobiology.
In our first aim we will define the neuronal landscape of the light organ, including neuronal position and identity
and the effect of symbiosis and bacterial products on both. To achieve this aim, we will develop new methods
for dual labeling of RNA and proteins in our system and adapt neuronal tracing techniques for imaging in the
light organ. In our second aim we propose to study the role of neuropeptide signaling on transducing microbial
signals from V. fischeri to tissues on the outside of the symbiotic organ. Specifically, we will determine the
location and dynamics of FMRFamide signaling in the light organ over the first three days of symbiosis and will
examine the effects of FMRFamide signaling on bacterially-mediated post-embryonic development. The data
arising from this proposal will not only lay the foundation for a powerful new model system, but will also
generate new resources and techniques for the community and provide new insights as to the role of the
peripheral nervous system in potentiating microbially-mediated development.

Public health relevance
NARRATIVE The vertebrate gut contains millions of bacteria, called the microbiome, that can have wide-ranging effects on host biology; in fact, recent studies have shown that the gut microbiome can drastically affect development and function of the brain and the nervous system of the gut. However, the large numbers of bacterial species in the gut and complexity of the vertebrate nervous system means that in order to understand how the microbiome interacts with the nervous system we need to find simple, manipulable systems in which to study these phenomena. We propose to use the association between the Hawaiian bobtail squid and its glowing bacterial symbiont as a simple, accessible, and manipulable model system in which to study interactions between beneficial microbes and animal nervous systems, focusing on the role of neurotransmitters in relaying signals between bacteria and their hosts.